Chemical Physiology Training Program

Project Summary
The goal of this predoctoral “Chemical Physiology Training” program (CPT) is to recruit and train a diverse
pool of students to develop the technical and professional skills needed to apply chemical biology tools and
methods to whole-animal and human studies in a safe, ethically responsible and rigorous manner. Students in
this program will be trained in both chemical biology and in physiology and will learn how and when to build
research teams with complementary expertise. Development of the CPT program is facilitated by a number of
changes to modernize OHSU's graduate programs' structure and curriculum using evidence-based practices.
The overall goals of these changes are to individualize graduate training according to each students scientific
and career interests, allow for just-in-time training in technical, operational, and professional skills, and aim
towards a time-to-degree appropriate with the future career goals of each graduate. This proposal builds on the
success of our Program in Biomedical Sciences (PBMS) and Neuroscience Graduate Program (NGP) and
takes advantage of the recent growth in Chemical Biology and Physiology across many departments at OHSU.
Students will be pulled from both the PMCB and NGP graduate programs. The administrative and mentorship
structures for those graduate programs will remain in place, while the new hub structure will facilitate
successful cross training of students and post-docs in an interdisciplinary learning community. We are
requesting 6 slots from NIGMS, which will be used to fund 3 students in years 2 and 3 of their graduate
training. OHSU and the Steinberg endowment for training in Physiology will fund an additional 3 slots/year.
Students will complete required coursework for their degree granting program and research rotations in year 1.
Students appointed to CPT will be required to select the following PBMS and NGP electives: Chemical Biology
Innovators, Principles of Physiology, Drug Discovery & Development (pharmacokinetics), Receptor
Pharmacology (pharmacodynamics), and the new course Interface of Chemistry & Physiology. Students will
take some of these courses during year 1 and then upon acceptance into CPT they will take the additional
courses in year 2. These classes, together with courses addressing quantitative analysis and statistics, rigor
and reproducibility, and the responsible conduct of research provide the academic core of the training program.
They are supplemented with journal clubs, seminars, and a full array of professional development courses and
activities. Students will develop a working knowledge of both chemical biology and physiology and will develop
deep expertise in one discipline. Students will receive training and mentoring in research project development,
written and verbal communication, and exposure to an array of job opportunities that utilize those skills. The 33
training faculty come from across OHSU, representing multiple departments, institutes, and schools. We aim to
grow by attracting and fostering a diverse group of students and faculty, and have implemented several
approaches to foster pipeline development and reach out to a diverse group of students.

Public health relevance
Project Narrative The goal this training program is to produce a new generation of scientists who will elucidate the fundamental mechanisms that undergird health and disease by applying chemical biology tools to understand physiology, pathophysiology, and medicine. A unique aspect of this training program is that students receive training in both chemistry and physiology in a medical school environment.